Computational Models of Adaptive Immunity to Influenza

PROJECT SUMMARY
The adaptive immune response underpins protection against influenza virus infection, and strengthening the
response is the goal of vaccination. However, we lack a good understanding of what factors determine a strong
adaptive immune response to vaccination, particularly in individuals with prior exposure to influenza virus. The
goals of the proposed study are to describe conditions under which strong, durable, and broadly protective
adaptive immune responses to influenza arise and to use mechanistic and statistical models to understand
precisely how these responses change over time, especially in response to vaccination. We will begin by
identifying adults with “good” (strong, durable, and broad) and less good (transient, narrow, and/or weak) B and
T cell responses in a randomized, placebo-controlled trial of repeat influenza vaccination. Participants will have
received the recombinant influenza vaccine Flublok one to four years in a row, while a control group will not be
vaccinated until year five. In the first phase of the proposed study, we will investigate participants’ antibody
neutralization landscapes and B and T cell repertoires and ask how infections, vaccinations, and individual-
specific factors shape the strength, durability, and breadth of the response, focusing on neutralizing antibodies
and T cell phenotypes that we and others have identified as correlates of protection. Our statistical and
mechanistic models will assess how exposures shape the evolution of B and T cell clones and the relationship
between B and T cell repertoires and the specificity of the serum neutralizing antibodies. We will also investigate
how B and T cell phenotypes, including their transcriptomes, relate to repertoire dynamics and the qualities of
serum antibody and T cell responses. We will re-assess correlates of protection from infection. These
foundational models will test many mechanistic hypotheses and involve exploration, including the use of machine
learning for prediction. Consequently, in the next phase of the study, we will use a distinct observational cohort
that includes vaccinated and unvaccinated participants from a wider age range to cross-validate our leading
models and hypotheses, including correlates of protection. This approach should increase the robustness of the
conclusions and deliver a set of statistical and mechanistic approaches that describe conditions leading to
different responses to vaccination, predict B and T cell repertoire changes in response to influenza exposures,
estimate multidimensional correlates of protection, and infer the dynamics of the adaptive immune response to
influenza in individuals over time to understand in detail how variable vaccine responses arise. Our data and
software will be findable, accessible, interoperable, and reusable (FAIR) to maximize their utility for other
researchers investigating the evolution of adaptive immunity to influenza and other pathogens.

Public health relevance
PROJECT NARRATIVE The study uses computational models to investigate why individuals vary in the breadth, strength, and durability of their immune responses after influenza vaccination. Using specimens collected from a randomized clinical vaccine trial and an observational study, we will analyze in depth the adaptive immune repertoires from people with “good” and “less good” vaccine responses, applying computational models to understand how different response types arise. These models can be used to design better vaccines and to anticipate how individuals will respond to vaccines.